Development: Clinical Trials Core

The experience of key technical personnel who will be responsible for the day-to-day operation: Drs. Wolff and Carbone are tenured Professors at their respective sites, experienced clinical researchers with a long-standing history of bench-to-bedside research. Both have been active in the administrative and clinical activities of clinical research including long-standing directorship of the Clinical Trials Core, active clinical research, service on institutional IRBs, clinical research mentoring, service on DSMBs, study design, analysis and evaluations. Both are clinically practicing oncologists in academic centers and have direct role for both education of fellows and patient care.